Assessing Cultures of Recovery in Tribal Communities - Administrative Core

PROJECT SUMMARY/ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core for the proposed NARCH XII program of activities will use the strategies and techniques
for generalized management, integration, and oversight that allowed us to successfully complete the goals and
aims of our previous NARCH VIII and NARCH X research and capacity building agendas. The Core will facilitate
the implementation of the proposed NARCH XII activities, keeping in mind three overarching goals: (1) building
tribal research, training, and collaboration capacity, (2) evaluating a new culturally-appropriate community-based
mental health first response system, xaʔtus for Mental Health (xaʔtus, the Salish word for First Face), and (3)
expanding xaʔtus by developing new course material and gaining new related insight from tribal youth and adults
in the US. The Administrative Core provides structural and functional administrative assistance, so that science
can prosper. The Center for Indigenous Research Collaboration Learning & Excellence (CIRCLE) Administrative
Core will fulfill four main functions in support of its Specific Aims. First, the Administrative Core will provide tools
and structure to promote collaboration among staff, consultants, and advisors to support innovation and promote
advancement of our Research Project and Capacity Building Project and the broader field of American
Indian/Alaska Native (AI/AN) addiction research. Second, the Administrative Core will provide organization,
information, support, and communication services that will inform decision-making and ensure workplace
efficiency across all activities and sites. The Administrative Core will ensure that the components of this
application have access to resources that are required for optimal performance to meet short- and long-term
goals, including appropriate expert services, space, supplies, and technology. Third, the Administrative Core will
provide a support system for personnel, offer day-to-day project management, administrative provisions, and
oversee grant-related compliance. Fourth, the Administrative Core will help promote the dissemination of
research findings to AI/AN communities and the larger scientific community, in coordination with the Tribal
Councils. The Administrative Core will coordinate with external advisors, campus liaisons, and funding bodies,
to obtain objective feedback related to the program of activities, and independent advice to promote advances
and innovation. A logic model describing the full set of CIRCLE inputs, activities, outputs, and outcomes provides
the Administrative Core with the guiding framework for ensuring the accurate and timely completion of the
proposed agenda.